Global Blood-Brain Barrier Disruption and Post-Stroke Cognitive Decline

Project Summary/Abstract
This study is focused on expanding our understanding of post-stroke cognitive impairment and
dementia (PSCID). Studies have found that patients who suffer a stroke are at increased risk for
developing subsequent cognitive decline. While this has been demonstrated epidemiologically,
the mechanism by which this occurs is not known. PSCID is a form of vascular cognitive
impairment and dementia (VCID). VCID has been linked to progressive changes in the white
matter, referred to as white matter hyperintensities (WMH), that are readily seen on magnetic
resonance imaging (MRI). It has been hypothesized that disruption of the blood-brain barrier
(BBB) precedes the development of WMH. Thus, imaging the BBB may be a way to determine
who is at risk for developing VCID. It is the central hypothesis of this proposal that PSCID is due
to acceleration of VCID brought on by the acute ischemic event and is characterized by global
disruption of the BBB which precedes the development of WMH. Thus we aim to: 1) Test if BBB
disruption detected on routine clinical MRI scans of the brain is predictive of PSCID, 2) Study
the mechanism of progressive WMH in post-stroke patients using serial research MRI scans to
measure BBB disruption of normal appearing white matter before it progresses to WMH, and 3)
Translate a novel MRI method into the clinical setting that uses arterial spin labeling (ASL) to
measure BBB disruption without the administration of exogenous contrast. To achieve these
objectives patients will be recruited from hospitals in the Johns Hopkins Health System. Patients
will be followed with serial cognitive testing to detect cognitive decline over a 3-year period. BBB
measurements will be extracted from the MRI scans done at the time of the evaluation for acute
stroke. A subset of patients will be followed with serial research MRIs. Research MRIs will be
used to track the progression of NAWM to WMH and its relationship to BBB disruption. These
research MRIs will also implement a novel ASL method for measuring BBB permeability to
determine if this method could be used instead of contrast-based methods. The long-term goal
of this research is to validate a biomarker for the pathogenesis of PSCID such that patients at
risk can be identified for therapeutic trials and potential therapeutics can be screened for their
effect on the pathology.

Public health relevance
Project Narrative The aim of this research is to develop biomarkers to predict who will develop post-stroke cognitive decline and to understand the pathogenesis of this disease. Specifically, the role of blood-brain barrier disruption will be studied. The potential impact of this research on public health is to develop strategies for mitigating the impact of Alzheimer's disease and related dementias (ADRD) on society.